CORE--BIOSTATISTICS AND ADMINISTRATION

The Administration/Biostatistics Core has two major functions. First, it will provide centralized administrative and fiscal management for all research projects and cores associated with the Program Project. These services will involve coordinating the programmatic aspects of the research activities of the participants and include fiscal overview, preparing and assembling yearly Progress Reports, manuscript and report typing, organizing and scheduling meetings and seminar speakers, and the general allocation of resources. The Biostatistics component will provide the bioinformatics necessary for the design and analysis of carcinogenesis experiments, analysis of gene expression array data and dual labeling results as well as general statistical tests. The Administration Core will be headed by Dr. Medina and assisted by Dr. Rosen, and staffed by a full time administrative secretary, Kathy Key. The Biostatistics component will be headed by Dr. Susan Hilsenbeck.